NYS AGM Food Laboratory Discipline Special Projects, Analytical Track 1 - Sample Collection - July 1, 2020 - June 30, 2025

NY AGM Food Laboratory - Project Summary/Abstract: The New York State Department of Agriculture and Markets (NY AGM) has an expansive food safety inspection program and a regulatory food safety testing laboratory. The New York State Food Laboratory (Food Laboratory), a division within the NY AGM, has a mission to provide expert state of the art analytical testing in support of food safety programs in New York State. The Food Laboratory, through food testing, provides support to the divisions of Food Safety and Inspection, and Milk Control and Dairy Services. It is the primary servicing laboratory for the New York manufactured food regulatory program and is accredited to the ISO/IEC 17025 standard and AOAC ALACC criteria. The Food Laboratory has comprehensive testing programs for foodborne pathogens and chemical agents in human and animal food. If funded for Special Projects Discipline and Analytical Track 1 ? Sampling Collection, the laboratory will continue agreements with Divisions of Food Safety and Inspection and Milk Control and Dairy Services to collect human and animal samples to fulfill the requirements under the following projects: (1) Chemistry/Human Food Product Testing, (2) Chemistry/Animal Food Product Testing, (3) Microbiology/Human Food Product and (4) Microbiology/Animal Food Product Testing.